Translation and Clinical Implementation of a Test of Language and Short-term Memory (STM) in Aphasia: The CORE-APHASIA Collaboratory: Advancing Robust Data Science & Sharing (CARDS)

PROJECT SUMMARY Aphasia is an impairment of language, affecting the production or comprehension of speech and the ability to read or write resulting from damage to the left hemisphere from stroke, head trauma or other neurological conditions. Aphasia affects any aspect of spoken and/or written language processing (e.g., comprehension, word retrieval) and can range from mild to severe. Language impairments in aphasia often have profound adverse effects on the individual's quality of life. Existing research efforts in aphasia have led to a wide range of measures, interventions and resultant datasets that yield more precise diagnoses and finely targeted treatment plans. A consequence of this much needed gain in diagnostic precision and treatment specificity has been a preponderance of underpowered single case and case series studies with little consistency of measurements or treatment content across groups, and multiple datasets that lack standardization and interoperability with limited mechanisms for open access and long-term sustainability. Thus, there is a critical need, for a technological infrastructure to support data standardization and aggregation, and collaboration amongst aphasia researchers. We have developed CORE-APHASIA, a biomedical database, knowledge repository, and “collaboratory” using an open-science platform with an award from the NIH Office of Data Science Strategy (ODSS). CORE-APHASIA relies on cloud-based open science resource and is timely and complementary to the goals of the parent grant that supports development of a clinical diagnostic tool for aphasia, the Temple Assessment of Language and Short-term memory in Aphasia (TALSA). This proposed project is aligned with NIH's strategic plan for data science, and aims to further advance the data ecosystem for aphasia researchers with a focus on ensuring FAIR- ness (Findable, Accessible, Interoperable, and Reusable) and TRUST-worthiness (Transparency, Responsibility, User Focus, Sustainability, and Technology) of CORE-APHASIA. For this proposed project, our primary research objective is to incorporate the FAIR and TRUST principles and processes within our exiting CORE-APHASIA biomedical data repository and “Collaboratory”. As part of this effort, we will assess and increase the alignment of our CORE-APHASIA data resource to optimize it's impact on the aphasia research community. Our specific aims are 1) achievement of desirable characteristics for data repositories including standardized data vocabularies; 2) establish FAIR-ness of the CORE-TALSA data repository using the 3 prong FAIR-ify standard approach and tools; and 3) establish TRUST-worthiness. Our final deliverable will be an improved more mature data repository that has a system of metrics and processes in place to enhance data sharing, access, and interoperability; increase usage, utility, sustainability and impact of the data resource, and to improve the ability to capture, curate, validate, store, and analyze clinical data in accordance with FAIR-ness and TRUST-worthiness.

Public health relevance
PROJECT NARRATIVE Aphasia is an impairment of language, affecting the production or comprehension of speech and the ability to read or write, resulting from stroke, head trauma or other neurological condition. Research to improve health related quality of life for individuals with aphasia has resulted in rich datasets and knowledge but rely on inefficient data structures that do not fully leverage efficient research and all that could be learned from existing datasets. This proposed project will follow guidance and processes addressed in the NIH Data Science Strategic Plan to align our existing data platform for aphasia research, CORE-APHASIA, with the FAIR (Findable, Accessible, Interoperable, and Reusable) and TRUST (Transparency, Responsibility, User Focus, Sustainability, and Technology) principles to improve the standardization, interoperability, and shareability resulting in a modernized CORE-APHASIA data resource and platform.